Core Grant for Vision Research

SUMMARY The overall goal of our Center Core is to provide expertise, facilities, and equipment to foster and expand vision research at the University of Wisconsin-Madison. This will be accomplished by four Cores. The Vector and Gene Delivery/Quantitative Molecular Biology Core will facilitate the use of gene delivery methods, qPCR and other molecular methods by core users. The Pathology and Imaging Core will facilitate the use of confocal microscopy, fluorescent and light microscopy, histopathology, specialized tissue staining methods, and image analysis by core users. The Animal Models and Organ Culture Core will facilitate the use of non-human primate, rodent and other animal models of ocular disease, the use of OCT, ERG, VEP to assess visual function, and the use of other visual structure and function outcome measures. The Biostatistics and Epidemiology Resource Core will facilitate proper study designs, the use of power calculations, proper use of statistical measures of significance, and proper data analysis methods for Core users.

Public health relevance
NARRATIVE The overall goal of our Center Core is to provide expertise, facilities, and equipment to foster and expand vision research at the University of Wisconsin-Madison. This will be accomplished by four Cores. The Vector and Gene Delivery/Quantitative Molecular Biology Core will facilitate the use of gene delivery and molecular biology methods by core users. The Pathology and Imaging Core will facilitate the use of microscopy, histopathology, specialized tissue staining methods, and image analysis by core users. The Animal Models and Organ Culture Core will facilitate the use of non-human primate, rodent and other animal models of ocular disease to assess visual function, and the use of other visual structure and function outcome measures. The Biostatistics and Epidemiology Resource Core will facilitate proper study design and proper data analysis methods for Core users.